The FIU Research Center in a Minority Institution (FIU-RCMI)

Modified Abstract Section: FIU-RCMI Overall ABSTRACT
The Research Center in Minority Institutions at Miami Dade’s Florida International University (FIU-RCMI) is supported by the largest NIH Award in the history of FIU. Since 2017, the FIU-RCMI has been devoted to developing and sustaining a national, clinical and behavioral research program primarily focused on HIV and substance use problems. We have provided extensive research support and training for early-stage investigators (ESIs), partnered with South Florida communities to develop and conduct health disparities research, and capitalized on our community connections to develop supplementary large-scale research. FIU, our ESIs, and our South Florida community partners all have benefitted from the NIMHD-funded FIU-RCMI. We are enthusiastic about submitting this competitive renewal proposal for our Center, which builds upon our earlier achievements, refines our approaches to ESI mentoring and community research partnership, and broadens our scope. Our scientific focus areas will include basic biomedical research, behavioral research and population science, and clinical/health services research, with two R01-equivalent projects. During the initial funding cycle of the FIU-RCMI, we concentrated on behavioral and clinical research primarily regarding HIV and substance use problems. More recently, with supplemental research funding, the hiring of new investigators, and the growth of our pilot studies and community research enhancement programs, FIU-RCMI research concentrations have grown to include behavioral, clinical, population, and basic biomedical research regarding Alzheimer’s Disease, the microbiome, app-based HIV prevention approaches, and precision cancer therapeutics. Our competitive renewal proposal reflects this growth. The FIU-RCMI is well positioned relative to FIU’s priorities, long-range goals and vision for health disparities-related research. Overarching goals of our proposed Center renewal include: 1. enhancing institutional health research capacity, 2. increasing investigator success in obtaining competitive extramural research support, 3. fostering an environment conducive to career development for ESIs, 4. disseminating research generally and specifically for advancing and improving health, and 5. establishing sustainable relationships with community-based organizations.

Public health relevance
The Research Center in Minority Institutions at Miami Dade’s Florida International University (FIU-RCMI) has provided extensive research support and training for early-stage investigators (ESIs), partnered with South Florida communities to conduct health research, and capitalized on our community connections for supplementary research. This competitive renewal proposal builds upon our achievements, refines our approaches to early stage investigator mentoring and community research partnership, and broadens our scope. Our scientific focus areas will include basic biomedical research, behavioral research and population science, and clinical/health services research, with two research projects.